NRSA Training Core

NRSA TRAINING (TL1) SUMMARY/ABSTRACT
Clinical/translational (C/T) scientists are increasingly important for cutting edge biomedical research that
achieves “bench to bedside to curbside” impact to address critical unmet health needs. To address these
needs, translational workforce development (TWD) is needed to train C/T scientists with new skill sets. These
skills will enable them to develop innovative strategies to address unmet health needs with effectiveness,
efficiency and economy. Critical factors for success will be skills for transdisciplinary work, ability to work
across the spectrum of laboratory science to clinical and public health research, and the ability to envision and
design implementation of advances in clinical and community settings. To address these needs, the CWRU
Clinical and Translational Scientist Training Program (CTSTP) will support C/T research training in both
predoctoral and postdoctoral phases. These programs will be coordinated with our KL2 program to share
training in team science, professional development activities and mentorship models. Together, these
programs will provide a complete pipeline for training and development of C/T scientists. In the previous phase
the CTSTP has focused on predoctoral training in combined degree programs, including expansion of
physician-scientist MD-PhD training into C/T areas and the establishment of a novel nurse-scientist DNP-PhD
training program. In the last 5 years the CTSTP has established two new PhD programs (Clinical Translational
Science; Systems Biology and Bioinformatics) and has launched its expanded dual-degree training in
Epidemiology, Biomedical Engineering, Nursing and other C/T areas. The CTSTP now proposes to further
develop predoctoral programs and add a new post-doctoral research training program that will cover a broad
range of clinical and research fields and encompass several applicant streams (post-doctoral training in the
CTSTP PhD program in Clinical Translational Science, C/T research fellowships, and trainees in participating
in research-track residencies/fellowships). The applicant streams will include physician-scientists, nurse-
scientists, dental scientists and other C/T scientists. Predoctoral and postdoctoral trainees will participate in a
core CTSTP curriculum with team science training, professional development activities and a rich set of C/T
research training activities (including RCR and IDPs). Criteria for acceptance to the CTSTP include a strong
academic record, commitment to a research-intensive career and evidence of skills for research. The program
will be governed by an Advisory Board and a Steering Committee; these will include representatives of all
participating institutions and programs. The CTSTP's robust mentor pool includes mentors with established
training records and funding from NIH or other research grants. Participating institutions include CWRU,
Cleveland Clinic, University Hospitals Cleveland Medical Center, MetroHealth Medical Center and the Louis
Stokes Veteran's Administration Medical Center. These sites are well equipped for cutting edge C/T research.